Institutional Career Development Core

The INvestigation of Co-occurring conditions across the Lifespan to Understand Down syndrome (INCLUDE)
supplement will support a promising early career investigator, Hannah Rea, to broaden her research and
related clinical experience in behavioral and cognitive disorders co-occurring with Down syndrome. Among the
most common, quality-of-life impairing, and understudied behavioral phenotypes associated with Down
syndrome are challenging behaviors, such as aggression or noncompliance. Challenging behaviors have
negative long-term consequences for individuals with Down syndrome and their families, including contributing
to decreased acquisition of skills that are critical for global functioning and independence. The proposed
project aims to identify and analyze the interacting effects of risk factors for challenging behaviors in children
with Down syndrome, which will inform interventions.
This project will investigate nonverbal and verbal IQ as predictors of severity of challenging behaviors,
moderated by executive functioning in 120 children with Down syndrome ages 6 to 14 years. The feasibility
and acceptability of measures will be assessed with 10 families of children with Down syndrome and 5 adults
with Down syndrome and latent modeling and multi-modal measures will be used to operationalize EF and
challenging behaviors. The same models will be investigated in an archival sample of children with autism
spectrum disorder (ASD), a disorder that overlaps in commonly co-occurring conditions and occurs in
heightened prevalence in children with Down syndrome. The archival sample includes children with a known
genetic etiology associated with ASD with (n=125) or without (n=87) intellectual disability, and with a DYRK1A
mutation, a candidate gene for Down syndrome (n=27), ages 3 to 24 years. The comparison to ASD will inform
whether existing evidence-based interventions for children with ASD may be adapted for children with Down
syndrome.
Dr. Rea will join the Institute of Translational Health Sciences (based at the University of Washington)
as a KL2 scholar and receive mentorship from a highly qualified team of senior investigators at the University
of Washington, Seattle Children’s Hospital, and the University of California, Davis MIND Institute. Through the
KL2 program, Dr. Rea will gain knowledge and skills in translational science through interactive didactic
sessions with the multidisciplinary KL2 cohort. Additionally, Dr. Rea will seek intensive training in research with
children with Down syndrome and their families, electrophysiology methods with children, and advanced
statistical training in structural equation modeling. The proposed mechanism will support her progression
towards establishing her own laboratory and applying for independent research funding to support a future
clinical trial investigating the trajectory of and interventions for challenging behaviors in children with Down
syndrome.

Public health relevance
Challenging behaviors, such as aggression or noncompliance, occur in almost all children with Down syndrome and negatively impact quality of life for the individual and family. The proposed study will be the first to comprehensively investigate cognitive and neuropsychological factors that impact the development of challenging behaviors in children with Down syndrome. Findings from this research will inform future interventions targeting challenging behaviors in this population.